NHLBI TRANS-OMICS FOR PRECISION MEDICINE (TOPMED) FOR THE CENTRALIZED OMICS RESOURCE (CORE) - RNA-SEQ

NHLBI's Trans-Omics for Precision Medicine (TOPMed) program started in 2014 as the flagship program supporting the development of precision medicine for heart, lung, blood diseases and sleep disorders. The main goal is to generate a large volume of genomics data that have sufficient statistical power for scientific discovery. The data are generated and processed first in TOPMed before being uploaded to external databases, database of Genotypes and Phenotypes (dbGaP) and BioData Catalyst (BDC) for researchers to access. In 2016, under TOPMed program, NHLBI funded nine (9) Centralized Omics Resource (CORE) centers that have generated approximately 200,000 whole genome sequencing and multi-omics data. As TOPMed enters its next phase TOPMed2.0 focusing on functional genomics and disease mechanism, the CORE needs to be upgraded to CORE 2.0 generating more functional genomics data, including omics data at single-cell resolution. CORE 2.0 needs to generate a large volume of functional genomics data and is in need of contractors that can provide a high capability of generating omics data.